Selective dissection of local and distributed neocortical inhibitory circuits underlying sensory representation

PROJECT SUMMARY/ABSTRACT
The research proposed here is aimed at furthering our understanding of causal relationships between early
neural circuit formation and adult behavior, and specifically how healthy brain development can go awry to result
in deficits in sensory processing across a lifetime. Towards a deeper understanding of normal and aberrant
neurodevelopmental processes, there is a critical need to deconstruct the driving pathophysiological
mechanisms between developmental cortical hyperactivity and emergence of persistent maladaptive cognitive,
sensory and social behaviors. Without such information, the promise of novel targets for early intervention in
neurodevelopmental diseases will likely remain limited. During the F99 Phase, I will test if developmental
hyperexcitation of pyramidal neurons leads to persistent adult hypersensitivity (Aim IA) and deficits in fast-spiking
inhibitory neuron recruitment (Aim IB)—key neurophysiological and behavioral signatures seen in autism
spectrum disorders and neurodevelopmental syndromes. In Aim II, I will complement my neurophysiological
training in high density electrophysiological recordings and perform two-photon imaging of prefrontal cortex
projections into sensory areas to test how they influence encoding and circuit dynamics regulated by local
inhibitory neuron subtypes. This work will contribute to understanding the neurodevelopmental origins of
hypersensitivity and will help to broaden our understanding of disturbances in spontaneous activity beyond
genetic, immune and environmental factors by providing mechanistic insight into causal cell-type specific roles
of pyramidal neuron and inhibitory neuron subtypes. The training for the F99/K00 Phases will complement my
deep background in developing molecular technologies to dissect neocortical local and long-range projections
driving complex behavior. In my own lab I will readily develop next-generation molecular technologies for
dissecting neocortical computations across temporal and spatial scales with increasing biological complexity
(genes, proteins, cells, circuits) underlying sensory processing.

Public health relevance
PROJECT NARRATIVE The research proposed here aims at a deeper understanding of how neural activity during development of the brain shapes circuitry determining adult behavior and sensory processing, paving the way for more focused research on potential therapeutic targets. This research is likely to be informative for understanding basic developmental processes of neural communication, as well as have applicability across neurodevelopmental and neurological diseases where sensory processing is disturbed with cell-type specificity. Training of the applicant will potentially lead to next generation molecular technologies that will dissect how neocortical cellular populations contribute to complex goal-behavior and sensation.